Development of immunocompetent melanoma brain metastases organoids

Abstract
Immune checkpoint inhibition (ICI) can control intracranial disease in approximately 50% of patients with
melanoma brain metastases (MBM), which is the leading cause of death for these cancer patients - implicating
that immune microenvironment (IM) modulation can be therapeutic in the brain. There has been a paradigm shift
in clinical management wherein immunotherapy can be considered rather than traditional surgery and/or
radiation. However, there is a lack of preclinical models available that model the IM in patient MBM, which are
needed to test and improve immune therapies (IT). Our goal for this R03 proposal is to develop and test a patient
derived organoid model that mimics the IM found in patient MBM, which will have future applications in the
development and optimization of IT strategies. The development of this model will provide foundational data to
study cellular cross-talk in the IM of MBM, which will be the focus of a larger NCI R01. Our laboratory has
experience using ex vivo patient derived brain organoids from surgical samples for precision medicine assays
and drug screening. Our preliminary data derived from single cell RNA sequencing (scRNA-seq) of patient MBM
samples demonstrates that CD8+ T cells in the parent tumor express exhaustion markers (i.e., PDCD1, CTLA4,
LAG3, and TIGIT) – supporting therapeutic strategies targeting T cell activation. Further, cell-cell communication
analyses of our scRNA-seq data suggests that cancer associated fibroblasts (CAFs) are the dominant cells
receiving T cell crosstalk in MBM - indicating that T cells modulate the extracellular matrix. We hypothesize that
patient derived organoid models need ECM to retain T cell characteristics of patient MBM and that an organoid
with ECM will provide an optimal model for testing IT strategies. The aims of this study are: 1.) To identify the T
cell phenotype in immunocompetent MBM organoids with and without ECM. 2.) To identify T cell phenotype
following ICI treatment in MBM organoids. The development of a preclinical, immunocompetent, ex vivo model
of MBM has yet to be accomplished and will facilitate the following innovations: i) establishment of biospecimen
workflow that will allow for preservation of tumor stroma and immune cells in brain metastasis organoids, ii)
identification of T cell-tumor cell interactions that can be targeted in the future, and iii) identification of biomarkers
of ICI efficacy in the brain. The innovations gained by this R03study will contribute to the lives of patients with
end stage melanoma as brain metastases is the leading cause of death in these patients. Our data will provide
a basis for a future NCI R01 application.

Public health relevance
NARRATIVE Immune checkpoint inhibition therapy controls intracranial disease in 50% of melanoma patients with brain metastases indicating immunotherapy can be clinically effective in the brain. Our study will develop patient derived immunocompetent organoids that can be used to study immunomodulation of the melanoma brain metastases microenvironment leading to novel therapies. By developing these strategies, we have the potential to improve the lives of up to 40% of melanoma patients who develop brain metastases which is the leading cause of death in these patients and portends a median survival of less than a year.